Mechanism-Based Targeting of Mantle Cell Lymphoma

Mantle cell lymphoma (MCL) is a non-Hodgkin lymphoma that remains incurable due to the development of
drug resistance, despite the plethora of therapies available. Each successive treatment failure is associated
with a more rapidly proliferating disease and fewer practical treatment options. For example, the BTK inhibitor
(BTKi) ibrutinib initially has unprecedented efficacy, but failure is virtually universal and is associated with
dismal outcomes. Understanding the genomic basis and mechanisms for drug resistance in MCL is therefore
urgently needed. Our goal is to develop superior therapies for MCL that are effective, durable, well tolerated
and amenable to patient stratification, by defining the genomic and molecular mechanisms for drug
resistance. Targeting the cell cycle represents a rational approach to MCL therapy, as dysregulation of CDK4
and cyclin D1 expression underlie unrestrained proliferation in disease progression. We have demonstrated
that induction of prolonged early G1 arrest (pG1) by inhibiting CDK4 with palbociclib not only prevents
proliferation of primary MCL cells but also reprograms them for killing by clinically relevant targeting agents
including ibrutinib and PI3K inhibitors (PI3Ki)s. Longitudinal functional genomics of serial biopsies from MCL
patients treated with either palbociclib or ibrutinib further uncovered a close association between clinical
response and inactivation of PI3K as well as activation of the tumor suppressor transcription factor FOXO1.
Moreover, chromatin remodeling appeared to be the proximal event that reprograms MCL cells in response to
CDK4 inhibition. Collectively, our findings suggest that through regulation of PI3K, FOXO1 and the
epigenome, induction of pG1 by CDK4 inhibition reprograms MCL for a deeper, more durable clinical
response to BTKi and PI3Ki. Supporting this hypothesis, in our phase 1 clinical trial of palbociclib + ibrutinib
(PALIBR) in recurrent MCL, the overall response rate was 67% with 43% complete responses. The responses
were rapid and durable; only 2 responding patients have progressed in the 32 months since the trial opened.
To further accelerate the development of targeted MCL therapies, we have developed a novel inhibitor for
protein arginine methyl transferase 5 (PRMT5), which is dysregulated in MCL and many other human
cancers. Inhibition of PRMT5 reverses PRMT5-catalyzed epigenetic marks, restores regulatory pathways and
kills ibrutinib-resistant primary MCL cells. Building on these novel findings and capitalizing on the upcoming
multi-center phase 2 PALIBR in recurrent MCL, we propose to achieve our goals with three integrated specific
aims: 1) to define the mechanism for clinical response to targeting CDK4 in combination therapy and identify
the resistance genomic markers; 2) to determine the role of FOXO1 and chromatin remodeling in cell cycle
therapy; and 3) to target PRMT5 in MCL. Collectively, the tools and knowledge assembled from these
innovative and timely studies should significantly advance therapeutic targeting of the cell cycle and the
epigenome in MCL and provide new insights into the mechanism of drug resistance in MCL and beyond.

Public health relevance
PROJECT NARRATIVE The overall goal of this Program Project application is to determine the genetic basis and the mechanism for drug resistance in mantle cell lymphoma, which remains incurable, and to develop novel therapies that overcome drug resistance. The synergy and collective strengths of this group of outstanding investigators will ensure that the best effort is made to achieve this goal. !